Implementation of a Hub and Spoke Model to Reduce Ultra Processed Foods in the School District of Philadelphia.

PROJECT SUMMARY
Ultra-processed foods (UPFs) are ready-to-eat (or ready-to-heat) industrial formulations of foods that are
characterized by high levels of added sugars, unhealthy fats, salt, and chemical additives. UPFs are
associated with poor dietary quality and increased risk of obesity and cardiometabolic risk factors in children,
but concerningly, the rate of UPF consumption is increasing among children. Schools can play an important
role in addressing these high rates of UPF consumption as school meal programs feed nearly 30 million
students daily across the U.S., and students eating school breakfast and lunch consume nearly half of their
daily calories in the school setting. However, schools often face many challenges to prepare scratch-cooked
meals—including lack of infrastructure and training for school staff to prepare school meals from scratch— and
therefore rely on UPFs to provide meals that minimize the need for equipment or preparation. This proposal
seeks to address these barriers with long-term sustainable solutions through the development of a ‘hub-and-
spoke’ model in the School District of Philadelphia; two full-service kitchens (‘hubs’) will receive the necessary
equipment and resources to enhance meal service and reduce UPFs at those schools, as well as at an
additional 8 schools (‘spokes’) that do not have functioning kitchen spaces and thus rely on pre-packaged,
UPF options. Additionally, through collaborations with a local farm and the integration of Controlled
Environmental Agriculture (CEA) equipment (e.g., hydroponic gardens) in the participating schools, more fresh
food options will be integrated into the menus at these schools with corresponding student engagement
opportunities. Overall, these investments will lead to high-impact, sustainable, and long term changes in the
meals provided, leading to reductions in students’ exposures to UPFs.

Public health relevance
PROJECT NARRATIVE Ultra-processed foods (UPFs) are industrial formulations of ready-to-eat foods that typically have high levels of chemical additives, added sugars, saturated fats, and sodium, and their consumption has been increasing at an alarming rate among children. Interventions in schools can be particularly powerful to reduce children’s exposures to UPFs as many children consume both school breakfast and lunch daily throughout the academic year. This study in the School District of Philadelphia will reduce the UPFs currently offered through investments to create a sustainable “hub and spoke” model in schools with full-service kitchens (‘hubs’) preparing scratch-cooked meals that incorporate locally grown foods, which will be transported to schools that do not currently have functioning kitchens (‘spokes’) throughout the district.